HD2A RASC - Pain Implementation Support Core

PAIN IMPLEMENTATION SUPPORT CORE: PROJECT SUMMARY/ABSTRACT
The ongoing opioid overdose crisis – the leading cause of accidental deaths among Americans – has at its
roots inadequately treated opioid use disorder (OUD) and pain. This reality has been recognized by the
National Academy of Medicine and the Centers for Disease Control and Prevention, among other major
organizations charged with protecting the public health, sparking an unprecedented influx of funding and policy
changes to stem the tide of overdose deaths. The nationwide attention and funding increase have driven a
marked rise in the development of evidence-based, high-quality pain treatments and treatment guidelines
addressing the full spectrum of public health need: from prevention to harm reduction to treatment to recovery
support. However, there has been woefully inadequate uptake of these treatments in real-world practice. For
example, primary care providers--the most frequent prescribers of long-term opioid therapy for pain--often lack
skills and/or time to fully implement evidence-based guidelines, putting already vulnerable patients at even
higher risk for opioid-related harms, including overdose, and poorly-controlled chronic pain. Effectively
translating research findings into practice and ameliorating these real-world quality of care deficits are the
domains of dissemination and implementation (D&I) science. As a key RASC core, the overarching goal of the
Pain Implementation Support (Pain-IS) Core is to support HD2A Innovation Projects in successful
implementation of effective pain interventions through the coordinated efforts of a highly expert collaborative
team, deploying and advancing cutting edge D&I methods. We will bring the best of D&I science to the pain
treatment quality gap, unifying implementation scientists and pain researchers—with the proximal goal of
enhancing research in the Innovation Projects and the ultimate goal of impacting the public health. Specifically,
in alignment with the other Cores, we will ASSESS the current status of key components of the Innovation
Projects on D&I capability in 5 key dimensions: a) evidentiary basis for the intervention; b) stakeholder
engagement c) contextual determinants; d) selection of implementation strategies; and, e) implementation
outcomes including the critically important but often overlooked domain of equity. We will ASSIST the
Innovation Projects using the information gathered in the ASSESS phase in order to: a) enhance motivation to
enhance their studies with tailored D&I approaches that draw upon the Core’s expertise; b) provide a D&I
Implementation Support Plan on the components above and using a shared decision-making approach to
determine how best to offer technical assistance (implementation support); and, c) to co-lead the RASC
Learning Collaborative. In concert with the RASC and other cores, we will ADVANCE the innovation projects
activities with respect to sustainment and equity: linking projects with the field at large, promoting projects’
impacts on policy/financing, and facilitating ongoing stakeholder engagement towards advocacy.